IDENTIFICATION OF GENETIC COMPONENTS FOR AGE RELATED MACULAR DEGENERA

The goal is to investigate the environmental and genetic factors involved in Age Related Macular Degeneration and to determine what factors influence its progression. The research project is now in its second stage- identifying and studying families with two or more affected family members.